Continuous metabolite and protein profiling for immune monitoring

Project Summary
The PI's research program aims to introduce novel wearable and implantable technologies that enable
continuous measurements of biochemical parameters for immune monitoring by addressing fundamental
scientific challenges associated with current biosensing methods. Accurate diagnosis of immune-related
diseases and realization of personalized medicine require real-time information of physical and chemical
parameters of the human body, which need to be continuously monitored at many different time scales from
minutes to days. Recent advances in bioelectronics enable many health and disease-related physical
parameters to be continuously monitored over long durations. However, continuous monitoring of biochemical
parameters in the human body remains extremely challenging. At present, very few biosensors are proven to be
clinically viable for continuous biochemical monitoring. Quantifying the temporal changes in the concentrations
of cytokines in body fluids is essential for characterizing time-resolved systemic inflammation across many
diseases. Current “end-point” methods such as enzyme-linked immunosorbent assay, Western blot, and
fluorescence-linked immunosorbent assay are not suitable for continuous monitoring of protein biomarkers, such
as cytokines. This is because of several limitations, including the reliance on external reagents and multiple
washing steps, time-consuming processes, and the need for highly trained personnel and bulky equipment.
Existing biosensors for real-time measurements of proteins do not have device built-in refreshing capabilities
and provide only a limited monitoring duration. In addition, most biosensors are limited to the quantification of
single analytes. Therefore, the PI aims to address these limitations over the next five years by developing a novel
biosensing platform that offers high sensitivity, specificity, and stability for real-time, quantitative, simultaneous,
and continuous monitoring of a panel of molecular biomarkers, including metabolites and proteins, over long
durations. Goal 1: Molecular encapsulation of biomolecules for thermal, chemical, and biological stability in
continuous monitoring. Goal 2: Multiplexed transistors for continuous detection and quantification of molecular
biomarkers. Goal 3: Soft and flexible wearable devices for automated multiparametric monitoring in vivo. The
outcomes of this proposal will enable real-time, quantitative, and continuous measurements of a panel of
molecular biomarkers for immune monitoring over long durations. The continuous molecular monitoring
technologies will serve as a platform to (i) enable timely diagnosis and prognosis of immune-related diseases
and medical conditions for prompt clinical intervention; (ii) function as molecular phenotyping tools to guide
effective therapeutic strategies; and (iii) provide valuable insight into the molecular mechanisms of those complex
and heterogeneous diseases and medical conditions.

Public health relevance
Project Narrative The proposed research is relevant to public health because it aims to design and develop a soft, wearable electronic platform that enables real-time, quantitative, simultaneous, and continuous measurements of a panel of molecular biomarkers for immune monitoring over long durations.